9TH INTERNATIONAL FLAVINS AND FLAVOPROTEINS SYMPOSIUM

The area of flavins and flavoproteins is a broad, but clearly and simply defined one. It covers all aspects of work pertaining to the chemistry and biology of compounds based on the isoalloxazine nucleus and on a very few closely related structures. Because of the extraordinary and perhaps unique versatility of flavin as a prosthetic group and its involvement in a variety of important biological oxidation and reduction processes, this area continues to expand rapidly. Interest in flavins ranges from theoretical chemistry to medical aspects. The 9th International Symposium to be held in Atlanta in 1987, will be one of a series which have been organized at 3-year intervals from 1965 onwards, the last having been in Brighton, England, in the summer of 1984. Because of the continued and increasing pace of research in this area, it seems important that regularly scheduled meetings should be held. Review lectures will cover the entire field and the meeting should bring together scientists from all over the world from a wide variety of disciplines, and promote valuable discussion and exchange of information. In addition, it should serve the purposes of keeping existing workers fully up-to-date with all aspects of the subject and of initiating young investigators into this important area of research.